A clinical trial to evaluate the impact of broadly neutralizing antibody VRC01 on HIV viral reservoir and maintenance of suppression in a cohort of early-treated children in Botswana

The Dual bNAb Treatment in Children Study (“Tatelo”) is an ongoing phase I/II, multi-site clinical trial of dual
treatment with two broadly neutralizing monoclonal antibodies (bNAbs), VRC01LS and 10-1074, offered to
HIV-1 infected virally suppressed children. The study is evaluating the efficacy of dual bNAbs for maintaining
viral suppression in the absence of ART among virally suppressed HIV-infected children who started standard
ART within 96 hours of birth (or soon after intrapartum infection).
All children in the Tatelo Study were recruited from the Early Infant Treatment (EIT) study (U01AI114235),
and have been followed from birth with frequent assessments of their clinical, virologic and immunologic
characteristics. Children who received at least 96 weeks of ART and met virologic entry criteria were offered
enrollment into the Tatelo Study. The intervention consisted of two PK and safety phases (single and then
dual bNAbs), followed by the main study intervention (dual bNAbs plus ART for at least 8 weeks, then dual
bNAbs alone for up to 24 weeks), and then a follow-up period when children were returned to ART alone.
The study is designed to evaluate three possible benefits of dual bNAb therapy in HIV-1-infected children:
1) to determine the duration of virologic control that can be maintained with dual bNAb treatment following
early ART, providing proof-of-concept that bNAbs may serve as a possible alternative to standard ART in
children with low viral reservoirs; 2) to investigate whether bNAb therapy is associated with changes in the
size and/or the cellular or clonal composition of residual viral reservoirs, which will be highly informative for
developing strategies to limit viral persistence and to destabilize viral reservoir homeostasis in pediatric
patients; and 3) to evaluate whether treatment with bNAbs is associated with qualitative or quantitative
changes in innate or adaptive antiviral immune responses, and if it facilitates the development of an
antiviral immune profile that can enable spontaneous post-treatment viral control.

Public health relevance
HIV-infected children who initiate ART in the first week of life may have both low viral reservoir and limited viral diversity, and are therefore an ideal population to evaluate strategies other than ART for maintaining viral suppression. This study will determine whether the broadly neutralizing antibodies VRC01LS and 10- 1074 can maintain viral suppression in early-treated children for a period of 24 weeks off ART, and will characterize changes in viral reservoir and immune responses during and after the intervention.